Genetic models for social attachment deficits in psychiatric illness

? DESCRIPTION (provided by applicant): Social attachments play a central role in most, if not all, levels of human interaction, from parent-child attachment, fraternity and kinship, friendship and social affiliation, to enduring partnerships with mates. Social attachment behaviors are also clinically very relevant, as several devastating conditions such as autism spectrum disorders and schizophrenia often manifest with a dramatic collapse of inter-personal interactions. These fascinating behaviors have traditionally been resistant to genetic and neurobiological approaches because of the limitations imposed by working on primates. Mice, the only genetically tractable mammalian model to date, appear not to display adult social attachment behaviors. This proposal seeks to establish the prairie vole (Microtus ochrogaster) as a model system to examine the deficits in social attachment behaviors that result from mutations in genes associated with psychiatric illnesses. Prairie voles are small mouse-like rodents that display strong social attachment behaviors such that mates typically form an enduring pair bond. Pair bonding results in dramatic changes in other social behaviors. These findings suggest that voles engage in a rich repertoire of social attachment behaviors that bear a striking resemblance to many of the social behaviors observed in humans. Pioneering work in the prairie vole has identified vasopressin (Avp) and oxytocin (Oxt), neuropeptides and hormones, as critical mediators of pair bonding. Strikingly, AVP and OXT signaling have also been implicated in social attachment type behaviors in humans. Given the deep evolutionary similarity between humans and other eutherian mammals, including prairie voles, these findings indicate that the genetics and neural control of social attachment may also be conserved between humans and prairie voles. Thus, findings in the prairie voles may directly inform our understanding of human attachment behaviors. We therefore propose to model the social deficits that manifest in psychiatric illness in this ideal model system for social attachment behaviors by generating prairie voles bearing mutations in genes implicated in neuropsychiatric disorders. While no single model system is likely to recapitulate the entire spectrum of complex symptoms that occur in human psychiatric illness, this model system will, for the first time, allow use to understand the neurobiology underlying the profound social deficits in these disorders. Autism spectrum disorders (ASD) and schizophrenia often result in marked social deficits, which manifest as significantly limited social supports and relationships, difficulty maintaining employment, and overall deficits in social skills. We propose 1) to generate prairie voles mutant for genes implicated in autism, SH3 and multiple ankyrin repeat domains 3 (SHANK3), and schizophrenia, Disks large homolog 2 (DLG2), 2) examine the pattern of deficits in social attachment behaviors that result from the loss of function of these genes, and 3) determine the change in patterns of neuronal activation that correlate with deficits in attachment related behaviors.

Public health relevance
PUBLIC HEALTH RELEVANCE: Social attachment behaviors are clinically relevant, as devastating conditions such as autism and schizophrenia often manifest with a dramatic collapse of inter-personal interactions, while disruption of such attachments also represents a significant component of mood and personality disorders. It has been difficult to model deficits in social attachment behaviors that occur in mental illness because traditional model systems lack these complex behaviors as adults, but if the prairie vole becomes tractable to reverse genetic approaches, it may well become the model organism of choice for studying the effects of psychiatric conditions on social attachments. We propose to develop genetic tools in the prairie vole to model social attachment deficits that result from mutations in genes associated with autism and schizophrenia will not only galvanize basic science research into the poorly understood phenomenon of social attachment, but it is also likely to be of utility in understanding and treating mental illnesses in humans.